Improving Outcomes for Mechanically Ventilated Patients with the Digital EZ Board

? DESCRIPTION (provided by applicant): Effective communication between patients and healthcare professionals is essential to achieve positive clinical outcomes. Patients who are unable to communicate effectively (e.g., patients with limited English proficiency (LEP), those who are hearing-impaired, aphasic, or have oral/tracheal intubation) experience extreme frustration, panic, anxiety, sleeplessness, fear, frustration, isolation and insecurity when attempting to communicate. For more than 25 years, communications boards have been used to assist patients with communicating their needs when they cannot speak or write. Vidatak previously developed the EZ Board(tm) as a manual aide that in published studies has shown some value in helping mechanically ventilated (MV) patients communicate more effectively. Despite these advances, as well as multiple studies validating the EZ Board as the preferred intervention by patients and nurses, the EZ Board(tm) still has many shortcomings, which likely reduces impact and standardization in practice. This proposed STTR project will overcome most of these limitations by developing a digital tool with iPad and android technology, VidaTalk, which meets the usability requirements of a broad range of critically ill patients. The goal of thi STTR is to commercialize a comprehensive, versatile, and technologically integrated digital communication application that will meet the communication needs of MV patients, including patients with LEP, and will achieve effective communication for critically ill patients and thereby impact outcomes. In Phase I, the feasibility and acceptability of developing such a device was demonstrated. Phase II extends the Phase I efforts by expanding the product capability in Aim 1 to include an android version, customizable communication, 30 different bilingual communications with pre-programmed text and speech output, pain assessment capability using multiple pain scales, freestyle finger drawing, and integration with hospital based pagers, communication devices and nurse call systems. Aim 2 will demonstrate usability with iterative user assessment testing in a clinical setting. Aim 3 will test the clinical efficacy of VidaTalk vi android application with MV patients using a randomized control trial. If successful, VidaTalk will demonstrate notable reductions in anxiety, sedation exposure, delirium/coma-free days, and patient-reported frustration, communication difficulty and improved satisfaction with ICU care compared to MV patients receiving the standard of care. Furthermore, by delivering a solution that may positively impact patient outcomes, VidaTalk may also help standardize practice with respect to the provision and use of communication resources with MV patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: Critically ill patients, being unable to communicate effectively, suffer unnecessarily; and, this suffering likely has a negative impact on their recovery due to poorly controlled anxiety and unrecognized, untreated pain and other symptoms, being unaware of what is happening as well as having a lack of knowledge of their own progress. This makes these patients more susceptible to harm and consequently they experience extreme frustration, panic, anxiety, sleeplessness, fear, frustration, isolation and insecurity when attempting to communicate. Technology and resources that are currently available for critically ill patients to communicate have many shortcomings that limit effectiveness in communications and outcomes for these patients and contribute to the lack of standardization for the provision of communication resources to patients who cannot communicate in clinical practice. This STTR will determine the specifications necessary to commercialize a comprehensive, versatile, and technologically integrated digital communication application that will provide an effective multi-lingual communication solution capable of being personalized for patients who cannot speak and/or have limited English proficiency.